Elucidating Mechanisms of CAR ML NK cell biology to treat cancer and infection

PROJECT SUMMARY
Candidate: During my training, I have been highly motivated to understand how cytotoxic lymphocytes can be
used as an adoptive therapy and how immune cells are regulated during immunotherapy. I have served as first,
co-, and corresponding author on numerous high-impact original research articles, representing advances in
basic, translational, and clinical immunology. I have successfully competed for career development awards that
have allowed me to continue my research interests. My long-term research goals are to understand the
mechanisms important for NK cell effector functions, how NK cells contribute to and are impacted by
immunomodulation and how host immune responses can promote or limit their NK cells as an effective cellular
therapy in human and murine systems.
Research Career Development Plan: As I begin my independent research program, I will utilize educational
and research resources aimed specifically at junior faculty at Washington University to strengthen my career
development. While I have the scientific training and expertise to perform the proposed studies, I will utilize the
opportunities at WUSM to prepare for my tenure-track position. Specifically, aspects of management,
mentorship, and the learning the administrative responsibilities of running a research laboratory (animal
protocols, institutional approvals, budget management).
Research Project: The long-term goal of this project is to improve our understanding of mechanisms operative
in the successes and failures of innate immune therapy. Memory-like NK cells were first identified in mice over
a decade ago and studies examining their persistence, anti-tumor responses, and metabolic adaptations to the
tumor microenvironment have laid the groundwork for both the human trials currently open to enrollment and the
studies proposed herein. One current barrier in the field is translating these novel immune approaches which
have had so much success in treating hematologic malignancies into successes treating solid tumors. We
hypothesize that ML NK cell differentiation combined with chimeric antigen receptor (CAR)-targeting will improve
NK cell trafficking, effector responses, and fitness in both allogeneic and autologous immunotherapeutic
paradigms. We will evaluate this concept against cancer and infection. These studies may reveal novel strategies
or therapeutic interventions for NK-cell based therapies that will likely be broadly relevant to other cellular
therapies. Completion of these studies will lay the scientific groundwork for both future R01 applications and for
a successful career studying the interactions of adoptive cell therapy and the host immune system.

Public health relevance
PROJECT NARRATIVE Because natural killer cells are important for controlling infections and cancer, clinicians are exploring them as a cellular therapy. Technologic developments have made tremendous progress in our understanding of factors that correlate with patient outcomes in these studies, but definitive human experiments using quick and economic clinical trials to evaluate specific hypotheses are not possible. However, understanding the interplay between adoptively transferred cells, the recipient immune system, and disease in an immune-competent/syngeneic environment will improve our ability to design clinical trials that have the highest chance for success.